Adipocyte-Derived Lipid and Mitochondrial Signals in Neuroprotectionand Brain Senescence

PROJECT SUMMARY
The long-term objective is to elucidate the mechanisms of adipocyte-brain communication and their impact on
glial function, neuroprotection, and brain aging, with potential implications for preventing dementia and age-
related cognitive decline. We will do this my executing two specific Aims: i) Investigate the role of adipocyte-
derived lipoproteins in glial phagocytosis, neuroprotection, and senescence. ii) Examine how adipocyte
mitochondrial oxidative phosphorylation impacts glial function and senescence. To achieve these aims, using
Drosophila as a model organism, we will explore how adipocyte-derived signals influence glial cell function,
particularly phagocytic activity. We will focus on two key adipocyte-derived signals: lipoproteins and mitochondrial
components. For Aim 1, we will investigate how lipoproteins and their receptors modulate glial phagocytic activity
through various molecular and cellular approaches, including knockdown studies, signaling pathway analyses,
and lipidomics. For Aim 2, we will examine the impact of adipocyte mitochondrial function on glial cells using
similar techniques, as well as targeted proteomics and Translating Ribosome Affinity Purification (TRAP). Our
research will employ genetic manipulation, confocal microscopy, biochemical assays, and high-throughput
sequencing to analyze glial function, lipid metabolism, and gene expression changes in response to altered
adipocyte signaling. We will assess the effects of these signals on glial senescence, lipid accumulation, and
neuroprotective capabilities under various metabolic conditions and during aging. This study aims to uncover
novel mechanisms of adipocyte-brain communication and their roles in neuroprotection and age-related cognitive
decline. The high degree of evolutionary conservation between Drosophila and mammals in adipocyte-brain
signaling and glial biology suggests that our findings may have broad translatable implications for human health,
potentially leading to new therapeutic strategies for improving age-related conditions impacted by diet-induced
obesity.

Public health relevance
PROJECT NARRATIVE This research aims to understand how fat tissue communicates with and affects brain health, particularly in relation to obesity and aging. By studying fruit flies, which share many biological similarities with humans, we will investigate how signals from fat cells influence the brain's support cells and their ability to protect against damage. Our findings could lead to new strategies for preventing or treating dementia and other age-related brain disorders by targeting the relationship between body fat, diet and brain health.